TUMOR SUPPRESSOR GENES IN HERITABLE MELANOMA MODELS

Three animal melanoma models have recently been identified in livebearing fishes of the genus Xiphophorus, comprising platyfish and swordtail species. Two of these are spontaneous melanomas occurring in different platyfish interspecies backcross hybrids; the other melanoma is LTV-induced in platyfish-swordtail backcross hybrids. It is likely that both spontaneous melanomas are regulated in tumor progression by tumor susceptibility genes that have not been previously characterized; the UV-induced melanoma has only been recently studied and its genetic regulation is as yet unknown. The genetic linkage map of Xiphophorus is the most complete of the few established in fishes, with 75 pigment, DNA, and protein markers distributed on as many as 20 of the 24 chromosome pairs. Therefore, by multipoint linkage analysis of allozyme and RFLP markers cosegregating with melanoma phenotype in backcross hybrids, genetic factors regulating progression to malignancy can readily be identified and characterized in these tumor models. Since there is evidence of genetic heterogeneity in human melanoma susceptibility, a synthesis of the results of investigating animal melanoma models with multiple genetic elements will promote a better understanding of the underlying genetic factors in melanoma formation and progression to malignancy in humans. To realize this overall goal, our specific aims are: (1) To analyze the genetic regulation of two recently described Xiphophorus interspecies spontaneous hybrid melanomas using multipoint linkage analysis to identify and map genetic regulatory elements, with the goal of identifying tumor susceptibility loci; (2) To investigate the genetic basis of a Xiphophorus hybrid melanoma useful as an animal model for UV-induced malignant progression by analyzing genetic factors that may contribute to LTV induction of melanomas; (3) To clone and sequence cDNAs that may be involved in tumorigenesis in Xiphophorus hybrid melanomas, including Xiphophorus erbB and RB homologues; and (4) To approach the molecular cloning of a known tumor suppressor gene by marker saturation using anonymous DNA RFLPs.